IGF::OT::IGF, RELAPSE PREVENTION MOTION VIDEO GAME, 6/15/2013-12/14/2013, N43DA-

Aim 1: Concept Testing: To elicit qualitative feedback from adolescents age in recovery, ages 15-18, in a focus group format (n=9) on the concept of Recovery Warrior and the proposed design features of Recovery Warrior.